Regulatory Science Track of the 2024 APHL Annual Conference

FOA PAR-23-072
Regulatory Science Track of the 2024 APHL Annual Conference
Project Summary/Abstract
APHL has the experience and competence to effectively add a high-quality Regulatory
Science Track to the 2024 APHL Annual Conference in Milwaukee, WI, in May of
2024 using the approach described in the proposal. This in-person event for the public
health laboratory community brings together leaders, scientists, policy makers,
regulators, and partners to share issues, trends and best practices driving public health.
Explorations in the realm of Regulatory Science in the setting of the 2024 APHL Annual
Conference will enable public health officials to improve submission of high-quality data
for regulatory action, improve investigations that rely on food testing and human illness
data, and reduce foodborne illnesses and deaths overall. This purpose aligns with
ORA's commitment to building laboratory capacity and capability, supporting the
groundbreaking work achieved through the GenomeTrakr network, continuing the
successes of state laboratories funded under the Flexible Funding Model Cooperative
Agreements, and integrating the food testing community with regulatory and public
health partners. A limited number of plenary and breakout sessions will be recorded and
made available after the conference on the APHL Learning Center (ALC) for a fee.

Public health relevance
FOA PAR-23-072 Regulatory Science Track of the 2024 APHL Annual Conference Project Narrative The new Regulatory Science Track of the 2024 APHL Annual Conference will enable leaders, scientists, policy makers, regulators, and their partners to share issues, trends and best practices driving public health. Information presented will help scientists in their efforts to submit high-quality data for regulatory action, improve investigations that rely on food testing and human illness data, and reduce foodborne illnesses and deaths overall. This purpose aligns with ORA's commitment to building laboratory capacity and capability and integrating the food testing community with regulatory and public health partners.